Approaches to Studying Social Motivation in Schizophrenia

Humans are highly social beings that are motivated to seek out, engage in, and maintain interpersonal
relationships with others. This fundamental human drive is referred to as social motivation. However, Veterans
with schizophrenia often experience disruptions in social motivation, resulting in poor social functioning.
Current evidence-based treatments are not sufficiently effective at improving impairments in social motivation
in Veterans with schizophrenia. To inform novel treatment development, new experimental approaches are
needed that will generate a more complete understanding of this pervasive problem. The current proposal
adapts a theoretical framework of social motivation from the National Institutes of Health (NIMH) Research
Domain Criteria (RDoC), which parses social motivation into two major components: social attention and social
memory. Social attention refers to the bias to preferentially attend to social aspects of the environment, and
involves stages of attention capture and sustained attention. Social memory refers to the ability to remember
who we interacted with to establish and maintain relationships, and involves stages of memory encoding and
retrieval. It is not clear the stage at which social motivation impairments begin to emerge for Veterans with
schizophrenia. Additionally, the relative contribution of these two social motivation components on social
functioning is not known. Social functioning in schizophrenia has traditionally been assessed using clinician-
rated interviews, which has limited specificity in understanding the complexities of real-world social functioning.
The overall goal of this proposal is to elucidate the relative contribution of the two social motivation
components (social attention and social memory) and their specific stages of processing on real-world social
functioning in Veterans with schizophrenia. The proposal utilizes an innovative multi-modal approach that
elucidates stages of processing with electroencephalography (EEG), and real-world social functioning with
digital phenotyping via smartphone technology. The results of this study have the potential to advance our
understanding of social motivation in schizophrenia and to identify specific treatment targets that will reduce
the cost and burden associated with this debilitating disorder at the VA.
In addition to addressing the above research goals, this Career Development Award (CDA) will provide the
applicant, Lauren T. Catalano, PhD, with the training in the areas of: (1) translational research in the social
neuroscience of schizophrenia and social motivation; (2) advanced electroencephalography (EEG) techniques;
and (3) digital phenotyping via mobile smartphone technology. The applicant’s career goal is to become a VA-
based psychology clinician researcher, working to improve the social disability experienced by Veterans with
serious mental illness. The training outlined in this CDA application will lay the groundwork for the applicant to
develop an independent research program within the VA focused on social motivation in schizophrenia. The
VISN 22 Mental Illness Research, Education, and Clinical Center (MIRECC) at the VA Greater Los Angeles
Healthcare System (GLA), and the University of California, Los Angeles (UCLA) provides an excellent
environment and infrastructure to complete the proposed study. The primary mentor will be Michael F. Green,
PhD, the Director of the VISN 22 MIRECC Treatment Unit, Director of the VA Research Enhancement Award
Program (REAP) for Enhancing Community Integration in Homeless Veterans, and an established researcher
in the field of schizophrenia. The applicant will also receive specialized training from an expert in EEG
methodology in Veterans with serious mental illness (Jonathan K. Wynn, PhD), and a leading expert in mobile
assessment methodology in Veterans with serious mental illness (Eric L. Granholm, PhD).

Public health relevance
Schizophrenia is a severe mental illness with major public health consequences for Veterans. Treatment of Veterans with schizophrenia in the VA health system accounts for a disproportionately large amount of the VA’s total health care budget (16-20%). Schizophrenia is the most expensive per patient psychiatric condition within the VA, with the majority of affected Veterans receiving some level of service connection. Pharmacological advances have helped to alleviate acute psychotic symptoms, such as hallucinations and delusions. However, current interventions are not sufficient to improve recovery and adaptive functioning, particularly in the social domain. The proposed study aims to systematically evaluate components of social motivation and their respective stages of processing to assess their influence on real-world social functioning. This knowledge can inform novel interventions that target the specific aspects of social motivation that are most disrupted in Veterans with schizophrenia.